SAFETY AND EFFICACY OF TIAGABINE HCL AS ADJUNCTIVE TREATMENT

The primary objective of this study is to compare the safety and efficacy of tiagabine HCL with carbamazepine and phenytoin when administered as the first add-on treatment for patients with complex partial seizures with or without secondary generalization incompletely controlled with carbamazepine or phenytoin monotherapy.